Exploring Mechanisms of Hepatitis C Virus-Associated Xerostomia

PROJECT SUMMARY/ABSTRACT
Chronic hepatitis C virus (HCV) infection remains one of the major causes of chronic liver disease, cirrhosis and
liver cancer, and is a major public health issue worldwide, with an estimated prevalence of 170 million people
globally. With no prophylactic HCV vaccine available, HCV remains difficult to eradicate. Newer generations of
Direct-Acting Antivirals (DAA) are effective in eliminating the virus in up to 95% of the patients, however, this
treatment remains out of reach for many individuals. Multiple HCV extrahepatic manifestations (EHM) have been
reported in patients with chronic HCV infection including chronic lymphocytic sialadenitis, and sicca syndrome
indistinguishable from Sjögren’s syndrome (SS). Yet, the mechanisms of the xerostomia and salivary gland (SG)
hypofunction remain controversial. Thus, understanding the clinical aspects of HCV-associated xerostomia is of
interest to better assess and manage this symptom. The objectives of this project are to determine the
pathophysiologic changes in the minor salivary glands (MSG) and changes in saliva composition associated with
chronic HCV infection and correlate these changes with clinical features of SG hypofunction (mentored phase)
and to mechanistically describe the HCV-associated xerostomia (independent phase). To achieve this goal, Dr.
José Maldonado-Ortiz will work with a mentoring team including Dr. John Chiorini (primary mentor), Dr. Blake
Warner (co-mentor), Dr. Raj Gopalakrishnan (collaborator), Dr. Valeria De Giorgi (collaborator), and Nobel
laureate Dr. Harvey Alter (collaborator). In Aim 1, the pathophysiologic changes in the MSG of patients with
chronic HCV infection will be determined and correlated to xerostomia and clinical features of salivary
dysfunction in patients with and without complaints of xerostomia. In Aim 2, the effects of HCV DAA therapy in
salivary physiology will be determined and correlated to clinical features of xerostomia. To understand the
pathophysiology of chronic HCV-associated SG dysfunction (Aim 1), and the effects of DAA therapy in SG
function, MSG biopsies will be collected and used to provide histopathological evidence of SG damage/changes
and research tissues to perform RNAseq and scRNAseq, in addition to sialometry, sialochemistry, and
ultrasonography of the major SG. Dry mouth and oral health related quality of life instruments will be completed.
In Aim 3, the mechanisms of HCV induced salivary gland dysfunction will be determined in vivo. To this end, an
adeno-associated virus (AAV) vector expressing the antigenic HCV envelope proteins E1 and E2 will be
transferred into the submandibular SG of mice to 1) better understand the HCV/host immune cell interactions
and 2) tissue changes that may result in SG dysfunction. In combination, these studies will reveal new information
about viral infections and the triggering or initiation of SG diseases such as SS. HCV infection offers a unique
opportunity to study viral induced SG dysfunction and can provide mechanistic data on the role of viruses in
driving inflammation, dysfunction, and damage in the SG.

Public health relevance
PROJECT NARRATIVE Dr. José Maldonado-Ortiz will evaluate patients with chronic Hepatitis C virus (HCV) infection before and after direct-acting antiviral treatment to determine the pathophysiologic changes in the salivary glands (SG) and correlate those changes to xerostomia and clinical features of salivary dysfunction. Additionally, a mouse model expressing HCV antigenic proteins will be used to better understand the HCV/host immune cell interactions and tissue changes that may result in SG dysfunction. HCV infection, which is the most common blood-borne pathogen in the US and has been associated with dry mouth, offers a unique opportunity to study viral induced SG dysfunction and can provide mechanistic data on the role of viruses in driving inflammation, dysfunction, and damage in the SG.